A PROTON THERAPY DELIVERY SYSTEM

The long rage goal of this program is the development and commercialization of a proton therapy delivery system that will lead to a substantial advancement over existing methods of cancer treatment with protons. The most important tasks of the innovative development required to accomplish this goal are the raster scanning system with 3D contouring capability and an isocentric delivery system, or alternative, to allow significant flexibility in the treatment direction. The Phase I effort completed the conceptual design and cost estimate for components of a beam delivery system including raster scanning magnets, small aperture bending magnets, modular achromatic bending magnet systems, a variable angle vertical magnet system, and permanent magnet transport systems of wide momentum acceptance. The design of these components were matched to the high beam quality of the proton accelerator being developed for this application. The Phase II program would construct and provide demonstration, with low energy beams, of the raster scanning system and a rotatable 90 degree achromatic bending system. Phase III, supported privately, would make commercial units available.